Program Integration and Management

PROGRAM INTEGRATION ABSTRACT This Program Project Grant is highly integrated and highly interactive, thereby providing investigators numerous opportunities for multi-disciplinary interdigitation between basic and translational researchers. It formalizes interactions among Project Leaders, Core Directors and other investigators who already have had productive collaborations in rexinoid chemistry, biochemistry and skin cancer prevention for several years. This process will continue through regular working group meetings, a secure website and experiments that unite scientists with unique, but complementary, areas of expertise, all of which are focused on the common goal of identifying effective, non-toxic rexinoids capable of preventing non-melanoma skin cancers in organ transplant recipients.

Public health relevance
This Program Project Grant is highly integrated and highly interactive, thereby providing investigators numerous opportunities for multi-disciplinary interdigitation between basic and translational researchers. This will be accomplished through regular working group meetings, a secure website and experiments that unite scientists with unique, but complementary, areas of expertise, all of which are focused on the common goal of identifying effective, non-toxic rexinoids capable of preventing non-melanoma skin cancers in organ transplant recipients.